Enhancing Precision Sleep Medicine in traumatic Brain Injury: Examining the feasibility of Home-Based Measurement of Circadian Timing

Veterans with traumatic brain injury (TBI) frequently experience insomnia, which is linked with delayed TBI
recovery, more severe functional impairment, and exacerbation of disabling TBI sequelae such as depression,
chronic pain, and fatigue. Current research suggests that TBI can impact numerous systems involved in sleep
regulation, suggesting that insomnia may manifest from various etiologies and that a “one-size-fits-all”
approach to treatment is likely inadequate. As such, it is necessary to differentiate Veterans who may benefit
from standard evidence-based treatments, such as Cognitive Behavior Therapy for Insomnia, from those who
may require enhanced treatments targeting specific underlying mechanisms.
An emerging body of evidence has established a link between circadian rhythm disruption and post-TBI
insomnia. A mismatch between circadian and desired sleep timing (i.e., “circadian misalignment”) is common
following TBI, as evidenced by perturbations of key circadian rhythms involved in sleep regulation (e.g.,
melatonin production), as well as the manifestation of circadian rhythm sleep-wake disorders. Importantly,
circadian-driven sleep disturbances require specialized treatments that target circadian rhythms (i.e.,
“chronotherapies”), such as timed sleep windows or enhanced light exposure, as standard treatment
approaches can fail to address or even exacerbate the underlying circadian misalignment. Thus,
circadian misalignment represents a novel and modifiable treatment target and has the potential to
improve functional outcomes in Veterans with TBI and insomnia.
Detection of circadian misalignment and optimal use of chronotherapies require the ability to measure
circadian phase (i.e., timing of the central circadian clock). However, current sleep medicine in TBI is
hampered by a lack of pragmatic options for measuring circadian phase. This is because laboratory dim
light melatonin onset (DLMO), the gold standard measure of circadian phase, is time and cost prohibitive,
requiring specialized sample (e.g., saliva) collection facilities and placing substantial burden on the patient.
Recently, novel methods of DLMO measurement have been developed that may enhance the accessibility and
practicality of circadian phase assessment, although, as of yet, they have not been used in Veterans with TBI.
The proposed single-arm, longitudinal study seeks to evaluate the feasibility of two methods of
measuring DLMO in the home environment of Veterans with TBI and insomnia: 1) direct measurement
of self-collected salivary melatonin; and 2) indirect estimation of DLMO using activity and light-
exposure data collected through actigraphy. Additionally, this study seeks to explore the relationships
between circadian misalignment, sleep disturbance, and functional impairment in Veterans with TBI.
The specific aims of this study are to: Aim 1) evaluate the feasibility of two methods of home DLMO
measurement (i.e., self-collected salivary melatonin and actigraphy data) in Veterans with TBI and insomnia;
and Aim 2) examine associations between circadian misalignment (i.e., the difference in timing between
DLMO and attempted sleep onset), sleep disturbance, and functional impairment. Veterans with TBI and
insomnia will be asked to wear a wrist-based actigraphy device for one week, which will collect data on light
exposure and sleep-wake states. They will then be asked to self-collect seven hourly saliva samples under dim
light conditions in their own home and mail them to a testing facility using a provided pre-paid shipping label.
Saliva samples will be used to directly measure DLMO and actigraphy data will be used to indirectly estimate
DLMO using established mathematical models of the human circadian pacemaker. Evaluating the feasibility
of home DLMO measurement is a crucial first step for enhancing precision sleep medicine for Veterans
with TBI and insomnia. Findings will inform the development and testing of tailored sleep interventions
for use with this patient population.

Public health relevance
Veterans with traumatic brain injury (TBI) frequently experience insomnia, which can delay their recovery and cause disability. Growing evidence suggests that misalignment between the timing of circadian rhythms—the daily changes in physical and behavioral processes that help the body stay healthy— and desired sleep may contribute to insomnia after TBI. Measuring the timing of the body’s central clock is necessary for detecting and treating this circadian misalignment; however, practical methods of measuring circadian timing have only been tested in a few limited research and clinical groups. This project aims to test the feasibility of two novel methods for measuring circadian timing in the homes of Veterans with TBI and insomnia, as well as explore the relationships between circadian health, disability, and sleep. In doing so, this research will help develop personalized treatments for insomnia in Veterans with TBI, which may aid recovery and improve functioning.